Tobacco Control Research Branch Scientific and Logistic Support Core Services

The Contractor shall provide scientific and logistical support services to the Tobacco Control Research Branch (TCRB) and the Division of Cancer Control and Population Sciences (DCCPS) in the conduct of:

1) scientific writing, editorial, and graphic services,
2) project management to support completion of scientific projects,
3) coordination of scientific conferences and meetings,
4) programmatic support for Tobacco Regulatory Science Program (TRSP) tasks, and
5) programmatic support for behavioral research tasks.